Detection, Radiosensitization and Theranostic Targeting of Metastatic Breast Cancer by PTPmu

Both inside the central nervous system and outside in the peripheral nervous system, cancer cells grow along
nerves as routes of invasion and metastasis called neural invasion. This growth is common in several carcinomas
including breast cancer and is associated with poor prognosis. Proteolysis of cell adhesion molecules (CAMs)
occurs in development, and growing evidence suggests this post-translational modification may promote tumor
migration and invasion on nerves that ultimately leads to metastasis to the brain in various tumor types including
breast cancer. The receptor protein tyrosine phosphatase PTPµ is a CAM that is proteolyzed in cancer cells to
generate an extracellular fragment that is a unique imaging biomarker of the tumor microenvironment. The PTPµ-
targeted agents we developed bind to this biomarker and recognize human brain tumors as well as invasive
primary breast cancer and breast cancer that has metastasized to the brain. Systemic delivery of the PTPµ-
targeted agent results in binding to tumor cells within minutes in xenograft models. Using a 3D cryo-imaging
system we analyzed the extent of cell migration and dispersal within the brain. We found that the PTPµ-targeted
agent labels 99% of all dispersing tumor cells far away from the main tumor mass on nerves in mouse models.
This proposal represents the convergence of our expertise in neuroscience, cell adhesion, imaging and cancer
to test if the PTPµ biomarker can be used to detect tumor growth along nerves leading to brain metastases.
Gold nanoparticles (AuNPs) have shown outstanding versatility in biomedical applications including
imaging diagnostics, drug delivery, and radiation therapy. In this proposal, we describe the development of
theranostic AuNPs for the detection and treatment of breast cancer metastases. We will achieve more sensitive
detection and treatment of invasive and metastatic lesions through the use of a three component theranostic
nanoparticle containing: 1) a highly specific targeting agent of the PTPµ biomarker in the tumor
microenvironment; 2) a protease-sensitive quenched near infrared fluorophore for fluorescent imaging; and 3) a
gold nanoparticle (AuNP) for sensitization to radiotherapy. We will test whether the PTPµ-targeted agents detects
nerve associated growth using 3D single cell resolution cryo-imaging that precisely tracks migration of individual
cancer cells on nerves. We will utilize our established human patient-derived xenograft models of metastatic
breast cancer and models that metastasize from the breast to the brain. Metastatic tumors are resistant to almost
all chemotherapeutics so “physical” killing strategies like radiation must be improved and employed for better
therapeutic outcomes. By delivering PTPµ-targeted conjugated AuNPs directly to primary and metastatic breast
cancer we will exploit the radiosensitization of AuNP to reduce the required dose of radiation needed for
radiotherapy thereby reducing collateral damage to normal surrounding tissues. We expect that these studies
will yield targeted nanoparticles that detect and treat nerve associated tumor growth while implicating CAM
proteolysis as a generalizable mechanism for detecting and treating tumor invasion on nerves.

Public health relevance
When cancer cells grow, invade and migrate along nerves in either the central (CNS) or peripheral nervous system (PNS), it results in the worst outcomes for patients yet there is very little knowledge about this process and no effective treatments. We hypothesize that a biomarker resulting from proteolysis of a cell-cell adhesion molecule can be utilized to detect and treat cancer growth along nerves in both the CNS and PNS. Here, we seek to enhance detection and treatment by developing a tumor-specific biomarker targeted theranostic agent that selectively enhances radiosensitization of primary, invasive, and metastatic breast cancer to the brain for improved radiation therapy.